DF/HCC Kidney Cancer SPORE (supplement)

Summary
The purpose of the Administration, Evaluation and Planning (Administrative) Core is to assure the
coordination of the Dana Farber/Harvard Cancer Center (DF/HCC) Kidney Cancer SPORE components and
to continue to provide oversight and leadership for the scientific, administrative and fiscal aspects of the
SPORE. The Administrative Core allows for the provision of stimulating intellectual activities, organization of
venues for planning future research through seminars and retreats, and the oversight of research and
spending. Drs. McDermott and Kaelin, the SPORE Directors, are committed to the success of the SPORE
and will personally monitor the progress of the Projects and Cores, oversee the Career Development and
Developmental Research Programs, and oversee all other proposed activities. As both SPORE Directors
and Leaders of the Kidney Cancer Program within the Dana-Farber/Harvard Center (DF/HCC), Drs.
McDermott and Kaelin have the authority and resources to ensure the success of this SPORE. The
Administrative Core of the DF/HCC Kidney Cancer SPORE will accomplish the goals of the SPORE by
following six specific aims: 1) Monitor research progress and plan for the future, 2) foster collaborative
research within and between SPOREs, 3) Integrate the DF/HCC Kidney Cancer SPORE into the structure
of DF/HCC, 4) Provide necessary resources and fiscal oversight, 5) promote patient participation,
particularly minorities, in Kidney Cancer research and treatment 6) Promote rapid dissemination of
significant research findings and free and open communication and resource exchange between the
DF/HCC SPORE and other institutions. As they have since early 2014, Drs. McDermott and Kaelin will
provide the tools to foster collaborations between the institutions inside and outside of the SPORE, to
leverage the considerable power of the SPORE in order to promote kidney cancer research.
SUMMARY
The Dana-Farber/Harvard Cancer Center (DF/HCC) SPORE in Kidney Cancer Biostatistics and
Bioinformatics Core (Core 1) collaborates and provides consultation on all research activities within the
SPORE including SPORE Projects, the Developmental Research and Career Development Programs, and
other SPORE Cores - to ensure the highest standards of scientific rigor in areas of study design, data
management and integrity, and data analysis and interpretation. The specific aims are to: (1) Provide
biostatistical and bioinformatic expertise for the planning and design, conduct, analysis, and reporting of
laboratory, genomic, animal, translational, clinical (including associated correlative studies), and
epidemiological studies for SPORE Projects, Developmental Research and Career Development Program
projects, and other SPORE Cores. (2) Provide consultation on all issues of data management and integrity,
including data collection, storage, transfer and quality assurance, on statistical and bioinformatic software and
programs, and on coordination of laboratory results with parameters and outcomes from clinical studies or
clinical/translational research databases. (3) Provide short-term biostatistical and bioinformatic consulting to
SPORE researchers. Organizing biostatistical and bioinformatic expertise as a shared resource core is a cost-
effective approach to ensure that collaboration is readily available to SPORE investigators and an effective
strategy to guarantee a high degree of integration among projects with interrelated analytic goals and needs.
The development of new statistical and computational methodologies for cancer research has resulted in an
expanded role for the statistician, bioinformatician and computational biologist in the research process and a
higher standard for what constitutes acceptable scientific evidence in a study. Biostatisticians and
computational biologists are professionally committed to staying on top of these developments and apply their
expertise to check assumptions, assure appropriate use, and interpret results and limitations--a challenge
beyond what can reasonably be expected of translational investigators.
Summary:
The first and foremost goal of the Tissue Acquisition, Pathology, and Clinical Data (TAPCD) Core 2 is to
maintain and expand the existing repository for specimens, including tissues, blood and urine from patients
with kidney tumors that have given consent to link their samples to clinical data. Included in this component
are the collection, freezing, and storage of fresh samples of kidney cancer and paired non-tumor tissue; the
collection, processing and storage of blood and urine; the identification and provision of samples of fixed
tissues, including construction of tissue microarrays (TMAs) from biopsy and nephrectomy samples obtained
from patients who have consented to allow analysis of these tissues. The caTissue system, which is the NCI
caBIG's biorepository tool for biospecimen inventory management, is currently used to track specimens
through every step of the requesting, shipping, and receiving process through the use of barcode technology.
Importantly, the TAPCD Core will continue to maintain a database of clinical data (CRIS) on all consenting
RCC patients. The value of the database is enhanced by the use of standardized pathology review procedures
and data collection procedures. The database and specimen tracking system provide an informatics link
among the participating Dana-Farber/Harvard Cancer Center (DF/HCC) hospitals, including the Dana-Farber
Cancer Institute and Brigham and Women’s Hospital (DFCI/BWH), the Beth Israel Deaconess Medical Center
(BIDMC), and the Massachusetts General Hospital (MGH). This allows seamless sharing of specimen
resources, linked to clinical outcome data, behind a secure data management system that is available to
SPORE investigators at all participating institutions. The protection of patient confidentiality is guarded
throughout the whole process, from specimen collection to use in research projects. The Biostatistics and
Bioinformatics Core is and will continue to be responsible for assisting in the data analysis, data auditing and
quality control.
Finally, TAPCD Core has provided and will continue to provide SPORE investigators a variety of services
critical to successful molecular analysis of human kidney tumors as well as animal models. These services
include: histopathologic review and quality control analysis of all tumor samples utilized in experimental
studies; macrodissection of frozen tissue samples and slide microdissection of paraffin-embedded or frozen
tissues to ensure high neoplastic cellularity for samples utilized in experimental studies; laser capture
microdissection (LCM) to provide ultra-pure tumor samples; performance of routine immunohistochemistry
(IHC) and multiparametric immunofluorescence (IF) stains on human kidney cancers (TMAs or whole tissue
sections); optimization and validation of antibodies to known and novel proteins for use in IHC and IF; analysis
of a broad range of IHC and multiplex IF stains using computer-assisted image analysis; development of novel
RCC models.
Summary Project 1
Inactivation of the VHL tumor suppressor gene is the initiating genetic event in most
clear cell renal cell carcinomas (ccRCCs) and increases the abundance of HIF2α, which drives
ccRCC growth. HIF2α inhibitors are active against some, but not all, VHL-/- ccRCCs in
preclinical models. In the last funding cycle we and others showed that HIF2 inhibitors (e.g.
PT2977) have promising antitumor activity in pretreated ccRCC patients. While the efficacy
signal seen with PT2977 has justified the launch of a pivotal trial that could lead to its regulatory
approval, some ccRCC patients fail to respond to HIF2 blockade. Moreover, the patients that
do respond to PT2977 monotherapy eventually relapse in most cases. We need biomarkers
that identify patients who are likely to respond to HIF2α inhibitors (predictive biomarkers) and to
understand the mechanisms of resistance to such agents. Finally, de novo and acquired
resistance is also a problem with standard of care kidney cancer therapies (e.g. VEGF
inhibitors). We therefore need new therapeutic targets in kidney cancer. Ideally, drugs against
these new targets would be active as single agents and could be combined with existing agents,
with the combinations increasing response rates and decreasing therapeutic resistance.
Two genes are synthetically lethal with one another when mutation of either gene alone
is tolerated but inactivation of both genes causes cell death. This paradigm has been validated
in the clinic with the activity of PARP inhibitors against BRCA1 mutant tumors. In our last
funding cycle we discovered that VHL and CDK4/6 have a synthetic lethal relationship.
Moreover, we showed that the hyperdependence of VHL-/- ccRCC cells was NOT driven by
HIF2. In keeping with the latter, we showed that CDK4/6 inhibitors were active against VHL-/-
ccRCCs, irrespective of their HIF2 dependence, and enhanced the activity of PT2977 against
HIF2-dependent VHL-/- ccRCC.
In aim 1 of this proposal we will conduct a phase 1/2 trial of the CDK4/6 inhibitor
abemaciclib, alone and in combination with PT2977. In aim 2 we will search for additional
genes that are synthetic lethal with VHL. We will leverage our ability to do synthetic lethal
screens in both human cells and drosophila cells as a means of identifying genetic interactions
that are likely to be robust. In aim 3 we will use genetic approaches to identify the mechanisms
by which cells become resistant to HIF2 inhibitors. This aim could eventually yield new ways of
predicting which ccRCC patients will respond to HIF2 inhibitors as well as new ways to
circumvent resistance.
Summary: Project 2
Anti-PD-1-based therapies have transformed the management of advanced renal cell carcinoma
(RCC), leading to durable responses in a subset of patients. Despite this progress, the optimal
therapeutic strategy (anti-PD-1 monotherapy versus dual checkpoint inhibition and dual
checkpoint inhibition versus VEGF and PD-1 inhibition) for individual patients remains unclear, and
too many patients still do not receive durable benefit from any of the PD-1 blockade-based therapies.
Moving forward, the critical challenges are (i) how to best match a patient to an immunotherapy
regimen, and (ii) understanding the key drivers and resistors of anti-RCC immunity following
PD-1 blockade. Our unique access to a rich collection of samples from several front-line PD-1-
blockade-based clinical trials and our comprehensive immunopathology and immunogenomics tool-
kit for deeply dissecting the biologic features tumor cells and the immune microenvironment,
uniquely position our group to address these challenges. To achieve the next paradigm shift in the
treatment of patients with RCC, we hypothesize that an improved understanding of the
expression state of RCC cells and their immune microenvironment at baseline provides
critical information that will uncover targets for novel therapies and will rationally guide PD-1
blockade-based combinatorial therapy. We aim to clarify first-line therapy decisions by developing
biomarkers for durable benefit from anti-PD-1 monotherapy, nivolumab/ipilimumab and axitinib/
pembrolizumab combination therapy using existing tissue collections, and then explore/confirm
the value of these markers in the context of prospective phase III trials comparing the
nivolumab/ipilimumab combination to either nivolumab monotherapy or axitinib/pembrolizumab.
Ultimately, our efforts to establish a predictive model of durable benefit will help determine the
appropriate RCC population to receive PD-1/CTLA-4 or PD-1/VEGF blockade, as well as unveil
those patients who receive equal benefit from anti-PD-1 monotherapy or who require a different
therapeutic approach. Moreover, we will use complementary analyses across patient samples
to comprehensively characterize immune cell composition and functional state, determine target
tumor antigens, and specific TCRs that mediate an effective anti-tumor response in RCC with
the goal of ultimately developing novel immunotherapy approaches that enhance or induce specific
and effective anti-tumor immunity. This work has the potential to optimize the application of
currently effective anti-PD-1-based therapies for patients with advanced RCC and to provide new
and effective immunotherapy approaches for those destined to not benefit optimally from current
regimens.
Summary: Project 3
While immune checkpoint inhibitors (ICI) have revolutionized the treatment of many cancers, including
metastatic clear cell renal cell carcinoma (ccRCC), the development of agents that overcome resistance to
anti-PD-1/PD-L1 based therapy represents a critical unmet need for ccRCC patients. We have shown that the
B7 family member HERV-H LTR-associating 2 (HHLA2) is expressed in the majority of ccRCC and recently
have discovered an inhibitory receptor (KIR3DL3) for HHLA2. Monoclonal antibodies that selectively block the
HHLA2/KIRDL3 interaction, which we call the HHLA2 Inhibitory Pathway (HIP), could be an important means
to enhance anti-tumor immune responses. In this proposal, we will study the expression of HHLA2 and it
receptors in kidney cancer on tumor cells and immune cells and the relationship of HHLA2 and PD-L1
expression on tumors cells. Using clinically annotated specimens from clinical trials of patients with ccRCC on
anti-PD-1 therapy, we will determine whether HHLA2 expression is associated with lack of response to PD-1
therapy. We will elucidate the regulatory pathways that are similar and different between HHLA2 and PD-L1 to
better understand the expression of these immune checkpoints in kidney cancer and how their expression may
change over the course of tumor progression and selection pressures. We will identify the optimal reagents for
activating T cells and NK cells through the HHLA2:KIR3DL3 pathway in both in vitro and in vivo models. Our
results will direct the selection of humanized blocking antibodies of HHLA2 Inhibitory Pathway that will move
into primate toxicity and human Phase I clinical trials during year two of this grant.

Public health relevance
Narrative: The Administrative Core has been vital to the successful function of the SPORE. It has handled the scientific, administrative and fiscal responsibilities of the SPORE, maintained the expanded communication and educational efforts of the Program with newsletters and conferences and fostered additional research collaborations both within and outside DF/HCC. It has carried out an annual review of SPORE Projects and Cores, directed the selection of Career Enhancement Program Awardees and Developmental Research Projects and shepherded a thorough selection process for new Projects to be included within the initial SPORE competitive renewal and this competitive renewal application. Narrative: Organizing Biostatistical and Bioinformatic expertise as a shared resource core is a cost-effective approach to ensure that collaboration is readily available to SPORE investigators and an effective strategy to guarantee a high degree of integration among projects with interrelated analytic goals and needs. The primary role of the Biostatistics and Bioinformatics (B&B) Core of this kidney cancer SPORE is to ensure that research conducted in the SPORE benefits from efficient experimental design and data analysis; quantitative methods used in SPORE research are appropriate for the design of the study and for the data, and assumptions required for these methods are evaluated and data collected in the Projects are managed and subjected to rigorous quality control to minimize the possibility of errors and are organized within an overall data model and framework that facilitates inter-project collaboration. Narrative: The TAPCD Core 2 is essential to the success of all the three SPORE Research Projects as well as all future Career Enhancement Awards (CEPs) and Development Research Projects (DRPs) via the provision of clinically annotated and highly characterized human kidney cancer specimens, the performance of sophisticated molecularly-based pathological assays on human tissue specimens and animal model tissues, and the development of novel models of kidney cancer. Narrative Project 1 Most clear cell renal cells carcinomas, the most common form of kidney cancer, are caused by mutation (alteration) of the VHL gene and resulting activation of a protein called HIF2. Drugs that inhibit HIF2 appear promising, but not all patients respond to them and it is highly unlikely they will be curative when used as single agents. This project seeks to understand how clear cell renal cell carcinomas become resistant to HIF2 inhibitors and to identify other proteins that, like HIF2, are selectively required by kidney cancer cells lacking VHL. Narrative: Project 2 PD-1 blockade-based therapies have transformed the management of advanced renal cell carcinoma (RCC), but too many patients still do not receive durable benefit, and it remains unclear how to best match the right immunotherapy regimen to an individual patient. By leveraging our unique access to informative tumor samples from anti-PD-1 clinical trials and our comprehensive immunopathology and immunogenomics tool-kit for dissection of the tumor-immune microenvironment, we aim to develop biomarkers for durable benefit (to clarify first-line therapy decisions) and determine the key drivers of anti-PD-1 response (and resistance) in RCC. This work has the potential to optimize the application of currently effective anti-PD-1-based therapies for patients with advanced RCC and to provide new and effective immunotherapy approaches for those destined to not benefit optimally from current regimens. Narrative Project 3 In this proposal we show that expression of the B7 family member HERV-H LTR-associating 2 (HHLA2) is present in the majority of ccRCC and may serve to suppress T cell function and promote resistance to PD-1 blockade. We have developed antibodies that selectively block the binding of HHLA2 to a newly discovered inhibitory receptor (KIR3DL3) and enhance anti-tumor responses. Our goal is to identify therapeutic antibodies that block the HHLA2 Inhibitory Pathway and test the optimized agent in human ccRCC clinical trials.